Acquisition of 600 MHz NMR QCI-P CryoProbe and CryoPlatform

PROJECT SUMMARY
Funding is requested to obtain a Bruker Biospin QCI-P CryoProbe and CryoPlatform to be installed on an
existing Bruker Biospin 600 MHz NMR magnet system. The requested instrumentation provides enhanced
sensitivity and capabilities for modern NMR experiments, particularly experiments utilizing the 31P nucleus in
studies of lipids, phosphoproteins, and nucleic acids. The requested instrumentation will be used by an
outstanding set of scientists at Columbia University, at the New York Structural Biology Center, and other
nearby research centers. Research conducted on the 600 MHz NMR spectrometer ranges from fundamental
studies of structure/function relationships in biomolecules, to molecular conformational dynamics, to elucidation
of mechanisms of health and disease. The requested instrumentation will dramatically enhance the hardware
capabilities of the existing 600 MHz NMR spectrometer to conduct cutting-edge research.

Public health relevance
PROJECT NARRATIVE NMR spectroscopy is a critical method used for biological research conducted at Columbia University, the New York Structural Biology Center, and other regional research centers. The requested NMR cryogenic NMR probe and associated instrumentation will be installed on an existing 600 MHz NMR spectrometer. The new instrumentation replaces obsolete components and provides new capabilities enabling research ranging from understanding fundamental biological processes in normal and pathological states to discovery of potential new drugs for treatment of diseases.